A Multimodal Imaging Approach to Understanding Neural Hyperexcitability

DESCRIPTION (provided by applicant): Neurons communicate by sending excitatory and inhibitory signals. Not surprisingly, numerous disorders of the nervous system are associated with a disturbance in the balance between these signals, producing either too much or too little activity. A classic example of imbalanced excitation and inhibition is the neural hyperexcitability found in epilepsy, a common disorder characterized by a propensity of neurons to fire in excessive synchrony, resulting in seizures. Much is known about the cellular biophysics and neural networks that contribute to epilepsy in animal models; however, less is known about mechanisms of human epilepsy. The proposed experiments will use state-of-the-art, multi-modal neuroimaging techniques to study neural hyperexcitability in patients with idiopathic generalized epilepsies. The experiments will combine visual stimulation paradigms and a computational framework based on current normalization models of sensitivity regulation in the visual system as a novel approach for understanding the pathophysiological mechanisms of epilepsy. Brain responses of patients with epilepsy will be studied with a combination of electrocephalography (EEG) and functional magnetic resonance imaging (fMRI) techniques. The use of visual stimulation will allow for precise manipulation of inputs to the brain and multi-modal functional imaging will allow the measurement of brain responses with high spatial and temporal resolution. In Aim 1, the balance of inhibition and excitation will be studied in cortical visual areas using a visual masking paradigm. EEG source imaging will be used to address the nature and cortical site of hyperexcitability. In Aim 2, high resolution fMRI will be used to measure visual responses in the lateral geniculate nucleus of the thalamus to determine if this structure participates in the epileptic brain network. In Aim 3, visual responses around the time of occurrence of epileptiform brain activity will be examined for premonitory patterns in the transition from normal to abnormal brain activity. The results of these studies not only have implications for developing novel treatment and biomarkers for diagnosis and management of epilepsy, but the methods developed can be applied to other brain disorders of altered neural excitation/inhibition and be extended to other sensory modalities. Outstanding resources and mentorship are available at the Smith-Kettlewell Eye Research Institute and at UCSF in the Epilepsy Center. Drawing on these resources, this proposal will combine training in advanced neuroimaging techniques and clinical research experience to allow the candidate to meet his career goal: to explore the basis of electrophysiological disorders of the human brain in order to improve the well-being of patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: Epilepsy is a common neurological disorder that affects almost 3 million Americans at an annual cost of about $15.5 billion. This proposal will contribute to the identification of the basic mechanisms of seizure generation that will lead to the development of cures and of tools that will validate such cures. Epilepsy is a common neurological disorder that affects almost 3 million Americans at an annual cost of about $15.5 billion. This proposal will contribute to the identification of the basic mechanisms of seizure generation that will lead to the development of cures and of tools that will validate such cures. __SpecificAimsTextDelimiter__ Specific Aims In this career development award application, I propose to study brain responses in patients with idiopathic generalized epilepsies (IGE) with the goal of providing a principled understanding of the site and nature of their underlying neural hyperexcitability. IGE is a major class of epilepsy syndromes characterized by absence, myoclonic, tonic-clonic seizures and intermittent abnormal brainwaves called generalized spike wave discharges (GSWs), which are detectable by electroencephalography (EEG). A traditional notion, supported by the International League Against Epilepsy (ILAE) classification scheme of epilepsies, is that patients with IGE, in contrast to localization-related epilepsy, have normal brain structures and no well-defined seizure focus. What then is the origin of neural hyperexcitability in IGE? Answers to this question will lead to improved therapy of this common disorder. We will address this question by measuring the brain's visual responses in IGE patients. Our hypothesis is that visual responses reflect the underlying hyperexcitability of IGE. A rationale for our approach is the observation that photosensitivity, the propensity of photic stimulation to trigger EEG abnormalities or clinical seizures, is much more prevalent in IGE than other epilepsy syndromes or the general population, suggesting that the visual system is prone to engage the epileptic mechanism. In a pilot study, we have found that patients with IGE have larger visual evoked potentials (VEPs) to high contrast stimuli compared to normal controls without epilepsy, supporting the notion of neural hyperexcitability. Visual signals enter the brain along well-defined pathways involving a series of subcortical and cortical areas. These areas can be stimulated with precisely calibrated visual inputs and their activity measured using neuroimaging methods. Over the last half a century, a vast body of knowledge has been acquired about the neural machinery of primate vision. The mentors' laboratories have developed a wide array of techniques for non-invasive analysis of function throughout the visual pathway. The proposed experiments will provide me with training in these methods: VEP recording, EEG source localization procedures, and functional magnetic resonance imaging (fMRI). Mastery of these techniques will enable me to complete the proposed studies of the visual system in IGE patients and to design an independent research program centered on brain disorders in humans. In Aim 1, we will test a model of hyperexcitability using a visual masking paradigm and EEG source imaging. The goals here are to identify neural hyperexcitability from the brain's visual responses and to determine whether it is caused by increased excitation, decreased inhibition, or both. These alternatives will be tested against visual responses recorded in the presence of a superimposed stimulus (mask). As discussed in Background, visual masking manifests as a reduction of response to a test stimulus in the presence of a mask. Masking or suppression reflects a modulation of neural sensitivity (termed "gain control" in the vision literature). Additionally, we know that different visual areas have different gain control characteristics. We will compare response suppression in cortical visual areas to test the secondary hypothesis that the expression of hyperexcitability may differ between brain areas. In Aim 2, we will study visual responses in the human lateral geniculate nucleus (LGN) and in the primary visual cortex (V1) using fMRI. The primary goal here is to determine whether hyperexcitability can be detected in the visual thalamus of patients with IGE as predicted from animal models. We will compare visual responses in patients and normal controls in both the LGN and V1 using high-resolution fMRI. A secondary goal is to determine whether cortical feedback modulates LGN responses by measuring response suppression in the presence of oriented mask stimuli. If suppression in the LGN is orientation tuned, then cortical feedback is implicated because the LGN neurons themselves are not tuned for orientation. In Aim 3, we will measure visual responses around the time of occurrence of generalized spike wave discharges to determine whether there are time-dependent changes associated with GSW discharges. We hypothesize that there will be a build-up of hyperexcitability culminating in GSWs. This aim will provide preliminary data for future studies on the temporal dynamics of neural hyperexcitability in epilepsy. Building on my background in engineering, neuroscience, and neurology, the training proposed here will provide me with the skills and experience to become an independent investigator in translational research. Aim 1 will provide training in high-density EEG and source localization procedures. Aim 2 will provide training in advanced fMRI techniques. Aims 3 will produce preliminary data necessary for future R01-funded studies of the mechanisms of hyperexcitability in human epilepsy. The results obtained from these experiments will increase our knowledge of the mechanisms of generalized epilepsies and identify biomarker of hyperexcitability for purposes of diagnosis and therapy.